Fundamental Training Program in Biochemistry and Molecular Biology Research

Abstract:
This proposal meets a critical need to strengthen the foundations of basic science by developing a program to
train students in biochemistry and molecular biology. UNMC has outstanding translational research in cancer,
neuroscience and other clinically relevant foci, all of which rely heavily on training in foundational biochemistry
and molecular biology. Despite this, we do not yet have a training program designed to bolster this crucial
fundamental area of research. The overall goal of our proposal is to enhance training in basic biochemistry and
molecular biology through the funding of 9 predoctoral students, 3 of which will come from internal UNMC
support. The program will rely on a carefully vetted list of experienced and motivated mentors, as well as new
mentors who will work in tandem with more experienced mentors. The program will select highly qualified and
diverse predoctoral students and provide them with outstanding training in scientific rigor, critical thinking, and
the bench skills necessary to succeed in academic or biomedical industry research. Training will not be limited
to research skills, but will provide exposure to a wide range of careers, and to develop the requisite skills in
professionalism, leadership, organization, time management, teaching, oral presentations, scientific writing, etc.
The proposed training program includes formal didactic courses, including a key discussion-based course in
critical thinking in biochemistry and molecular biology directed by the PI of this proposal, as well as journal clubs,
seminars, oral and poster presentations and other opportunities for scientific discourse. The program is designed
for students to complete their training within a 5-year window and to produce an outstanding cadre of graduates
that will contribute significantly to the Nebraskan and US scientific workforce.

Public health relevance
Project Narrative: This training program in the fundamentals of biochemistry and molecular biology is designed to equip the next generation of scientists with the skills and basic knowledge that provide the foundation for all modern biomedical science. Key to our mission is to enhance the diversity of our trainees by recruiting and retaining a diverse student body. Students who graduate from this program will be trained in critical thinking, ethical and independent research, and a variety of key skills in biochemistry and molecular biology that will lead to employment in academic and biomedical research in industry, teaching, and a variety of additional science careers.